Developing real-time personalized TMS to target residual corticospinal connections after stroke

PROJECT SUMMARY
Stroke commonly disrupts the corticospinal tract (CST) and impairs hand function. Transcranial magnetic
stimulation (TMS) interventions that target and strengthen residual CST connections are promising candidates
for improving poststroke hand function. To maximize their therapeutic effects, such interventions must repeatedly
activate the residual CST and enhance its neural transmission. We and others recently showed in neurotypical
adults that resting brain activity spontaneously alternates between EEG activity patterns (brain states) that
predict strong and weak CST activation. TMS interventions also preferentially enhance CST transmission when
delivered during strong CST states but instead diminish CST transmission when delivered during weak CST
states. However, virtually all poststroke TMS interventions are uncoupled from the current brain state, such that
only a fraction of TMS stimuli coincide with brain states during which the beneficial effects of TMS are likely to
be strongest. To resolve this issue, poststroke TMS interventions should be delivered solely during brain states
reflecting strong CST responses. Given that each stroke survivor has a unique pattern of brain damage and
recovery-related brain reorganization, these brain states must be fully personalized. We recently developed a
personalized machine learning framework that successfully identifies electroencephalography (EEG) activity
patterns that predict strong and weak CST states in neurotypical adults. Our framework is fully personalized and
is therefore unaffected by lesion-related changes in brain structure and/or function, making it ideal for application
in the poststroke brain. In this project, we will use this framework to establish the mechanistic rationale and
methodological foundation for future personalized brain state-dependent TMS interventions that target and
strengthen the residual CST after stroke. In Aim 1, we will use our machine learning framework to identify
personalized brain states that predict strong and weak residual CST activation in chronic stroke survivors; we
will also evaluate relationships between our framework’s performance and functional and structural metrics of
poststroke CST pathway integrity. Results of Aim 1 will establish poststroke brain state-dependency of residual
CST output and the relationship of this state-dependency to CST integrity. In Aim 2, we will develop and validate
a real-time EEG algorithm that accurately delivers TMS during personalized brain states reflecting strong and
weak CST activation in neurotypical adults. Results from Aim 2 will demonstrate the technical feasibility of
personalized, real-time brain state-dependent TMS. Overall, this project fits the scope of the NIMH/NINDS R21
mechanism because it will develop a novel neuroengineering approach that can in the future enhance residual
CST transmission and promote paretic hand function in stroke survivors.

Public health relevance
PROJECT NARRATIVE Maximizing the therapeutic effects of transcranial magnetic stimulation (TMS) interventions on poststroke motor function requires that these interventions be delivered during poststroke brain states during which TMS best activates the residual corticospinal tract and enhances its neural transmission. In this project, we will use machine learning to identify personalized EEG brain states that predict strong and weak residual corticospinal tract activation in chronic stroke survivors (Aim 1) and develop a real-time EEG analysis algorithm that accurately delivers TMS during personalized EEG brain states in neurotypical adults (Aim 2). Results will provide the mechanistic rationale, methodological foundation, and preliminary data for future personalized brain state- dependent TMS interventions that target the residual corticospinal tract after stroke.